PENICILLIN G /IV CEFTRIAXONE THERAPY FOR NEUROSYPHILIS IN HIV POSITIVE PATIENTS

This is and open-label, randomized equivalence study to evaluate two treatments: IV penicillin G and IV ceftriaxone for the treatment of neurosyphilis in HIV-seropositive patients.